Pittsburgh Biomedical Informatics Training Program

DESCRIPTION (provided by applicant): The University of Pittsburgh proposes a five-year renewal of its training program in Biomedical Informatics. The T15 grant is currently entering its 25th consecutive year. Our program is notable for the long and distinguished history of biomedical informatics research in Pittsburgh, the continuous evolution and refinement of our educational programs, the strong institutional commitment to biomedical informatics and our training program, and the rich biomedical and computational research environment in which our training program is set. The program has an administrative home in the Department of Biomedical Informatics (DBMI) within the University of Pittsburgh School of Medicine. DBMI provides space, equipment, and financial support for training program administration, faculty, graduate students and postdoctoral scholars. The program is supported by an interdepartmental core faculty of 29 faculty members, including all 17 faculty members with primary appointments in DBMI. The Training Program Director, a tightly knit leadership group of faculty co- directors, and two experienced staff members support the overall operation of the program. The Pittsburgh BMI Training Program offers research training in all four sub-disciplines of Biomedical Informatics: translational bioinformatics, clinical research informatics, healthcare/clinical informatics, and public health informatics. Additionally, we also offer specialized research training in dental informatics. Students in our T15-funded training program may pursue an MS or PhD in Biomedical Informatics, an MS or PhD in Intelligent Systems - Biomedical Informatics Track, an MD/PhD through the Medical Scientist Training Program, or advanced postdoctoral research. The training program has undergone significant enhancements during the past funding period including a new core curriculum, improved advising structure, improved program evaluation plan, and enhanced efforts to recruit trainee candidates, including candidates from under-represented minorities and disadvantaged backgrounds. Enhancements for the proposed funding period include new advanced graduate seminars, new professional development content, and enhanced training in the responsible conduct of research. We have a strong track record of success in training biomedical informatics researchers in all sub- disciplines. Trainees from our program are publishing research articles in high impact journals in the field, winning national awards for their research, writing successful K grants and individual fellowship awards, and securing research positions in academics, industry and government upon graduation.

Public health relevance
This grant proposes the continuation of the university of Pittsburgh biomedical informatics training program. The grant would support predoctoral and postdoctoral students for research training in all four sub-disciplines of biomedical informatics: healthcare/clinical informatics, translational bioinformatics, clinical research informatics, and public health informatics.